PREVENTION OF VASCULAR &NEURAL DYSFUNCTION IN DIABETIC RATS BY C-PEPTIDE

C-peptide, a cleavage product from the processing of proinsulin to insulin, has been considered to possess little if any biological activity other than its participation in insulin synthesis. Injection of human C-peptide prevented or attenuated vascular and neural (electro-physiological) dysfunction and impaired Na+- and K+-dependent adenosine triphosphate activity in tissues of diabetic rats. Non-polar amino acids in the mid-portion of the peptide were required for these biological effects. Synthetic reverse sequence (retro) and all-D-amino acid (enantio) C-peptides were equipotent to native C-peptide, which indicates that the effects of C-peptide on diabetic vascular and neural dysfunction were mediated by non-chiral interactions instead of stero-specific receptors or binding sites. Tissue sorbitol levels were measured by GC/MS and were not affected by C-peptide.